LONG TERM CARDIAC EFFECTS OF DOXORUBICIN AND MEDIASTINAL RADIATION

To determine the incidence of subclinical cardiac toxicity to patients who have been previously treated with either Doxorubicin or mediastinal radiation.